Administrative Core

PROJECT SUMMARY
The overarching goal of the Administrative Core is to oversee and coordinate all scientific, regulatory,
administrative and fiscal responsibilities of the Program Project grant. To achieve this, the Administrative Core
has outlined the following specific aims: 1) Provide strategic leadership and direction by ensuring integration of
all Projects and Cores by managing all oversight strategies; 2) Ensure efficient management of resources by
realigning resources based upon recommendations from the External and Internal Advisory Boards, in
collaboration with the Executive Committee (Program Leaders and Project/Core Leaders) 3) Facilitate effective
communication and collaboration by coordinating and overseeing all scientific, regulatory, administrative, and
fiscal interactions between institutions, and organizing monthly meetings and annual retreats; 4) Monitor and
evaluate program progress and impact by setting milestones for Projects, ensuring accountability for high-
throughput data, and facilitating data sharing.

Public health relevance
PROJECT NARRATIVE Efficient management between performance sites is critical for the success of this Program Project, which will aim to explore innovative therapies for manipulating dysfunctional sphingolipid metabolism in AML. The Administration Core, in collaboration with the Executive Committee, External Advisory Board, and Internal Advisory Board, will oversee the Program's scientific and regulatory activities and milestones, budget and available resources, and data management. These efforts will ensure optimal communication, resource management, and research productivity for the Program Project team.